DETECTION OF EARLY CNS MANIFESTATIONS IN HIV POSITIVE CHILDREN WITH HEMOPHILIA

The purpose of this research is to test the hypothesis that CNS manifestations are one of the earliest manifestations of HIV infection; and those seropositive children without opportunistic infections may already have widespread CNS involvement.